The role of salt inducible kinases in renal PTH action

Project Summary
Parathyroid hormone (PTH) maintains mineral ion homeostasis by interacting with the PTH/PTHrP receptor to
induce transcriptional and post-transcriptional modifications in target tissues. PTH stimulates resorption of the
mineral matrix in bone, and increases production of active vitamin D, calcium reabsorption, and phosphate
excretion in the kidneys. Despite the central role of PTH as a regulatory hormone, many of the downstream
intracellular target molecules that orchestrate PTH signaling events have yet to be identified. Characterization of
these pathways will expand current knowledge of the mechanisms governing mineral homeostasis, and suggest
new therapeutic strategies to counteract or restore PTH action in skeletal and renal disease. Recently, salt-
inducible kinases (SIKs) were identified as intracellular mediators of PTH signaling in osteocytes, and small-
molecule inhibitors of SIKs were found to mimic PTH action on bone in vivo. The objective of this proposal is to
explore whether analogous SIK-dependent PTH signaling pathways are active in the kidney. Aim 1 of this
proposal will explore the molecular mechanisms through which PTH/SIK signaling regulates CYP27B1
expression. In renal cells, human kidney organoids, and mice, both PTH and the SIK inhibitor YKL-05-099
increase expression of CYP27B1, the enzyme that converts inactive vitamin D to its active form. In renal cells,
PTH treatment results in decreased phosphorylation of SIK3 substrate CRTC2. The remaining intermediaries of
the PTH/SIK/CYP27B1 pathway will be characterized using in vitro experiments targeting molecules upstream
and downstream of SIK in renal cells and organoids. Chromatin Immunoprecipitation of CRTC family members
will identify the regulatory regions necessary for CYP27B1 transcriptional activation by PTH/SIK. Aim 2 will
define the role of PTH/SIK signaling in renal phosphate reabsorption. Mice treated with PTH or YKL-05-099 have
decreased serum phosphate levels, and YKL-05-099 treatment decreases phosphate transporter Npt2a
localization to the renal brush border membrane. These mice will be tested to confirm that SIK inhibition induces
phosphaturia in vivo. Three SIK family members will be knocked out in renal epithelial cells and their effect on
phosphate uptake assessed. Aim 3 will characterize the phenotype of mice lacking renal SIK1 and SIK3, and
explore the therapeutic potential of small molecule SIK inhibitors in CKD-MBD. The experiments described here
explore a novel role for SIKs in regulating PTH signaling in the kidney. In addition, mouse models developed for
this project will help to shed light on the crucial bone/kidney regulatory axis that controls mineral homeostasis
and bone health. This project also offers a novel application for SIK inhibitors, a class of drug currently studied
for their application in autoimmune and other inflammatory disorders, as treatment in later stages of chronic
kidney disease (CKD) and other disorders of mineral ion homeostasis that are unresponsive to PTH.

Public health relevance
Project Narrative The proposed research will contribute to knowledge of the regulatory axis that maintains mineral ion homeostasis through characterization of the intracellular signaling pathways of parathyroid hormone (PTH). In addition to describing novel roles for salt-inducible kinases (SIKs) in these pathways, it will also elucidate the mechanisms by which small molecule inhibitors that target SIKs can control mineral ion regulation in the kidneys by mimicking PTH action; these drugs are potential therapeutics for chronic kidney disease (CKD). The proposed research is relevant to the stated mission of the NIH and the NIDDK in that it will develop fundamental knowledge of an important endocrine function as well as provide novel approaches to reducing the burden of a common and chronic human disease.